Defining the neural ensembles of cocaine addiction

Project summary
Substance use disorder is a public health concern with no effective, long-lasting pharmacotherapies. A large
amount of effort has been put into defining the neural basis of addictive behaviors as well as the factors that lead
to the development of drug addiction. Past research has focused on the role of entire brain regions in mediating
addiction and recently, with advances in genetic approaches, genetically defined cellular populations. However,
recent work has shown that even within these defined populations, only a small percentage of cells are activated
to a given stimulus. Thus, moving forward, it will be important to identify the role of functionally defined neural
populations – termed ensembles – in addictive behaviors. Here, we aim to understand how ensembles in the
nucleus accumbens (NAc) that are activated by cocaine encode information and drive volitional cocaine
consumption. In this proposal, we will combine translational addiction models (mouse self-administration) with
optical tools for recording (fiber photometry) and manipulating (optogenetics) functionally defined ensembles to
elucidate what information is encoded within them and how they control complex behaviors. Together, this
proposal will give me the technical and theoretical training to answer complex questions about the neural control
of behavior and its dysregulation in substance use disorder. In Aim 1, I will define what aspects of cocaine-
associated behaviors these cells encode by using fiber photometry to record from cocaine-activated ensembles
in vivo while animals self-administer cocaine. In Aim 2, I will determine if these ensembles are sufficient to drive
self-administration by allowing mice to perform optical self-stimulation tasks in ChR2-tagged cocaine-activated
ensembles. Finally, in Aim 3, we will define how temporally specific activation or inhibition of these cells during
specific stimuli alters self-administration. By photo-stimulating or -inhibiting these cocaine ensembles during self-
administration, we can define the sufficiency and necessity of these neural populations in various aspects of
drug-taking (acquisition, consumption, and drug seeking/relapse). These experiments will provide new
information about the cell-specific populations that drive both initial drug taking as well as the behaviors that
define substance use disorder. By focusing on functionally defined neuronal populations, we will discover
subpopulations that would be unobservable when applying a priori broad genetic markers. Through these novel
findings, we will learn more about the mechanisms that mediate progression to drug addiction in specific
subpopulations so that we will be able, in the future, to decrease cocaine-taking behavior without producing
addictive or aversive effects.

Public health relevance
Project Narrative Cocaine use disorder is a major public health issue for which no effective pharmacotherapies exist; future targeted therapies will depend on identification of the specific subpopulations of cells involved in drug-seeking behavior. This project will aim to identify these neural populations – termed ensembles – that drive the initial reinforcing properties of cocaine as well as the progression to addiction, as defined by self-administration of cocaine. This will lead to a better understanding of the mechanisms involved in addiction and provide new targets for pharmacotherapy development.